Development And Production Of A Multiclade HIV-1 DNA Plasmid Vaccine

This project is designed to prepare a GMP quality investigational HIV vaccine and complete the preclinical and laboratory studies needed to begin a clinical trial. The Vaccine Research Center (VRC), NIAID is developing a novel prime-boost HIV vaccine strategy directed at the three most globally prevalent HIV subtypes (clades). VRC's HIV prime-boost candidate is designed to elicit immune responses to HIV sequences from clades A, B and C which together cause about 90 percent of incident HIV infections around the world. In November 2002, the VRC Clinical Trials Core launched a Phase I clinical study (VRC 004) of a multiclade, multigene DNA vaccine at the NIH Clinical Center (Bethesda, MD) as the first step in developing the prime-boost regimen. a next-generation 6-plasmid multiclade, multigene DNA vaccine was manufactured and entered Phase I clinical testing in August 2004 (Study VRC 007). This product has since been evaluated clinically as a single agent and as part of a DNA prime-adenovector boost regimen in several Phase 1 and 2 clinical trials in U.S. and international sites. Production of Phase II materials has been completed.